IL -1 and TNF alpha in the development of COPD

Emphysema is an abnormal enlargement of the respiratory spaces with destruction of the alveolar wall. Accumulating evidence suggests that repair processes involving elastin re-synthesis by interstitial lung fibroblasts limits alveolar damage and perhaps restore alveolar units. This proposal will focus on the inflammatory processes that hinder the repair of the alveolar matrix following injury. Our preliminary data reveal that mice deficient in the interleukin 1beta (IL-1beta) and tumor necrosis factor-alpha (TNF-alpha) receptors are more resistant to elastase injury than are wild type mice. We postulate that IL-1beta and TNF- alpha down-regulate elastin mRNA following elastase injury and induce apoptosis in the alveolar wall resulting in alveolar rupture and airspace enlargement. Preliminary data indicate that these mediators function to decrease elastin transcription via cis-acting elements located in the proximal elastin promoter. Electrophoretic gel shift assays utilizing nuclear proteins isolated from untreated and IL-1beta treated fibroblasts implicated NF-kappaB and C/EBP-beta proteins. In this proposal, our first aim will determine the mechanism whereby IL-1beta and TNF- alpha down-regulate elastin transcription. The second aim will characterize the signal transduction pathway utilized by these effector substances to down-regulate tropoelastin mRNA in lung fibroblasts The third aim will further examine the effect of elastolytic injury on mice deficient in the TNF-alpha receptors and type 1 (p80) IL-1beta receptors. We will also use caspace-11 deficient mice to clarify the role of apoptosis in this process. These studies will provide new insights into the pathogenesis of COPD and suggest new treatment options.